Early Case Management on Recovery From a Cardiac Event in Women

Outpatient cardiac rehabilitation (CR) is an exercise-based lifestyle program for patients who have experienced
a myocardial infarction, systolic heart failure, percutaneous revascularization or cardiac surgery. CR plays a
key role in secondary prevention, which is the prevention of subsequent cardiac events. CR has been shown to
reduce both cardiovascular mortality and one year hospital readmissions as well as improve quality of life,
exercise capacity, and physical function. Although the benefits have been clearly established for cardiac
patients, women are much less likely to attend CR than men. Based upon our own preliminary data (and the
medical literature), attendance at CR is determined by factors that vary in their importance between men and
women. These findings demonstrate that older age and poor social support are particular barriers to CR
participation in women. This information can guide efforts to increase CR participation and adherence in
women, areas which have received little study.
Case management (CM) has been effective at reducing cardiovascular risk and reducing hospitalizations
amongst cardiac patients. Further, CM has been effective at promoting attendance in a variety of health related
programs (for example, diabetes treatment or cocaine dependence treatment). The primary aim in this
randomized controlled trial is to examine the efficacy of early CM to promote participation and adherence in
CR. The CM model can identify individualized determinants of health and social needs to identify potential
barriers which may hinder CR enrollment. Additionally, the case manager will conduct a home visit and provide
individual counseling to address lifestyle changes including physical activity. Thus, a component of CR and
physical activity can be still be delivered for those unable to attend CR. The concept of CM to improve CR
participation and adherence has not been specifically tested in women, a vulnerable patient population. This
intervention, therefore, has the potential to increase utilization of CR and significantly improve health outcomes
in female cardiac patients.